KCNJ2-Induced Arrhythmia Mechanisms in CPVT and Heart Failure.

Arrhythmic sudden cardiac death (SCD) is a leading cause of death in the United States and can be caused by ionic current abnormalities occurring in genetic arrhythmia syndromes or acquired heart disease such as heart failure. This project focuses on the impact of cardiac inward rectifier current (IK1) on β-adrenergic-dependent genetic and acquired ventricular arrhythmias. IK1 maintains resting membrane potential, contributes to phase 3 repolarization, and is remodeled in heart failure. KCNJ2 encodes the ion channel Kir2.1 that forms the dominant protein pore subunit for IK1 in the human cardiac ventricle. Loss of function KCNJ2 mutations present with two clinical phenotypes, Adersen-Tawil Syndrome (ATS), composed of a triad of ventricular arrhythmias, dysmorphic features and periodic paralysis, or Catecholaminergic Polymorphic Ventricular Tachycardia (CPVT), which presents with adrenergic-dependent ventricular arrhythmias including polymorphic ventricular tachycardia (PMVT) and bidirectional VT (BiVT) with a lack non-cardiac ATS features. CPVT has been attributed to abnormal calcium (Ca2+) handling related to mutations in Ca2+ handling genes and the signature arrhythmia for CPVT, BiVT, is caused by Ca2+ overload. Unlike the other CPVT targets, Kir2.1 does not directly participate in Ca2+ homeostasis, yet Ca2+ modulates Kir2.1 by specifically blocking the outward Kir2.1 current. β-adrenergic stimulation activates protein-kinase A (PKA), which phosphorylates Kir2.1 with subsequent increase in outward Kir2.1 current. How Kir2.1 with CPVT-causing mutations fail to respond to PKA is unknown, particularly since the known CPVT mutations are not phosphorylation sites. Our central hypothesis is that under β-adrenergic stimulation, CPVT-causing Kir2.1 mutant channels have loss of outward current due to both lack of a PKA response and increased sensitivity to Ca2+ block, reducing outward current and thus repolarization drive causing membrane potential instability, favoring delayed after-depolarizations (DADs) triggered activity. Additionally, decreased IK1 in systolic heart failure is thought to be a key feature in ventricular arrhythmias and SCD. We hypothesize that IK1 is decreased predominately during β-adrenergic stimulation due to elevated Ca2+ in a manner similar to CPVT-causing KCNJ2 mutations. In this study, we will address these questions using a variety of cellular models and transgenic mouse models to determine the biophysical properties, Ca2+ sensitivity, phosphorylation state and arrhythmia mechanism of KCNJ2 mutations associated with a CPVT or an ATS phenotype and compare that to a heart failure model. Our innovative methods will include high-definition mass spectrometry, optical mapping and calcium imaging. The outcomes of this research will allow us to elucidate the mechanism by which β-adrenergic-dependent loss of IK1 can result in ventricular arrhythmia in CPVT and heart failure and compare that to an ATS arrhythmia mechanism. Elucidating the nuances of IK1 dysfunction and Ca2+ handling under β-adrenergic stress will lead to more evidence-based treatment approaches and prevention of SCD.

Public health relevance
PROJECT NARRATIVE Sudden cardiac death is a leading cause of death in the United States and is caused by cardiac ionic current abnormalities. One such ionic current is the inward rectifier current (IK1) which when disrupted can lead to sudden cardiac death syndrome in heart failure or in genetic arrhythmia syndromes. This project aims to better understand stress-induced loss of IK1, how this causes cardiac arrhythmias and will test the optimal treatment methods.